International Conference on Medical Image Computing and Computer Assisted Interventions (MICCAI) 2021

Project summary
The Medical Image Computing and Computer Assisted Interventions (MICCAI) Society is dedicated to the
promotion, preservation, facilitation of research and education in the fields of medical image computing (MIC)
and computer assisted interventions (CAI) including biomedical imaging and robotics; this is achieved through
the organization and operation of regular international conferences of the highest quality, and publications that
promote and foster the exchange and dissemination of advanced knowledge, expertise and experience by
leading institutions and outstanding scientists, physicians, and educators around the world. MICCAI
Conferences have their roots and origin in three separate but related conferences beginning in early 1990s,
which merged into a single annual conference in 1998. MICCAI Conferences have defined a new scientific
discipline over the years and have become the premier conference in the field, with their proceedings having
an impact factor comparable to high-impact computational journals. Conference topics include, computer
vision, image processing and machine learning for medical imaging, computer-aided diagnosis, computer-
assisted interventions & surgery, guidance systems & robotics, visualization and virtual reality, bioscience and
biology applications, specific imaging systems and new biomedical imaging applications, spanning disciplines
such as radiology, pathology, surgery, oncology, cardiology, physiology, and psychiatry.
The main MICCAI conference includes three days of oral presentations and poster sessions. The quality
and importance of poster presentations are on a par with those of oral presentations, with both undergoing a
rigorous double-blinded peer-review (~30% acceptance) and several presented papers becoming landmark
publications over the years and reaching up to 2,000 citations. The conference series also includes
community-driven software challenges, workshops and tutorials just before and/or after the main conference.
These satellite events focus in detail on the current status and advances in topics relevant to MICCAI and are
very highly attended. The MICCAI Conferences span the entire globe and attendees are typically from over 45
countries, with strong student representation (>40% in 2020). The MICCAI 2021 Conference will be held in
Strasbourg, France from September 27th to October 1st, 2021. MICCAI 2022 and MICCAI 2023 will be held in
Singapore and Vancouver, Canada, respectively. Since 2018, a Mentoring Program is also part of the
conference to connect students and early investigators with established mentors from academia and industry.
Along with the mission of the Women in MICCAI committee, this proposal requests funds to initiate and
ultimately sustain student and early investigator travel and registration awards to enhance diversity in
conference attendance (including women, underrepresented minorities, students with disabilities, and people
from disadvantaged backgrounds) and provide minority groups with a unique opportunity to reach an
international audience for career development and collaborations.

Public health relevance
Project narrative MICCAI is the premier meeting in the medical image computing (MIC) and computer assisted intervention (CAI) communities, having introduced several landmark papers and providing a springboard for young scientists to establish themselves in the field. This proposal requests funds to provide travel awards for students and early investigators to present their work with focus on minority groups and underrepresented populations, providing them with an opportunity for visibility in an established international audience, foster professional development and collaborations. MICCAI will be held in Strasbourg (France), Singapore and Vancouver (Canada) for the 2021, 2022 and 2023 editions, respectively.